Myopathy in purine metabolic disorders: a model for adenylosuccinate synthase deficiency

Project Summary/ Abstract
Inborn Errors of Purine Metabolism are linked with specific and often severe neural and muscle
dysfunctions. However, the precise mechanisms through which mutations in enzymes involved in the
synthesis of key biological molecules lead to these distinct outcomes remain unclear. This proposal
focuses on the investigation of adenylosuccinate synthase (ADSS), specifically the deficiency of the
muscle-specific isoform, ADSSL1, linked to progressive myopathy in humans. Because of the
importance of the purine nucleotide cycle in maintaining energy stores (ATP levels) in tissues like
muscle with intense energy requirements, the perturbation of the purine nucleotide cycle upon loss of
ADSS activity is proposed to underlie phenotypes. However this hypothesis has not been investigated
because there are no established animal models for study of this disorder. The primary objective of this
research is to develop a C. elegans model for ADSS deficiency. C. elegans, with its powerful genetic
system, provides an ideal platform for uncovering the etiology of myopathy and mobility phenotypes
associated with ADSS deficiency, a crucial step in envisioning novel therapeutic strategies. ADSS
deficiency in C. elegans manifests in mobility dysfunction and metabolic perturbations. The specific
aims are structured as follows: Aim 1 focuses on developing genetic tools for the analysis of adss-1
function. The plan focuses on developing a degron-based system for temporal and spatial control of
ADSS-1 function and engineering human disease allele knock-ins. These tools will be used to
determine tissue-specific, developmental, or acute functions of ADSS-1, as well as to characterize
structural defects in muscle cells and broader metabolic changes in metabolism that are associated
with adss-1 knockdown. Aim 2 involves investigating alternative hypotheses about the etiology of
various adss-1 phenotypes and testing candidate therapeutics. Comparisons with other genes in the de
novo purine biosynthesis pathway and purine nucleotide cycle pathway will elucidate the role of these
pathways in phenotypic outcomes. Supplementation and genetic experiments will assess the role of
ADSS-1 product (S-AMP) and purine homeostasis in phenotypic outcomes. Finally, candidate
therapeutics, including the ADSS product S-AMP, will be tested using the C. elegans model. The
anticipated outcomes include significant progress toward therapeutic strategies for a disorder lacking
treatment options. Insights gained will contribute to understanding how purine metabolism influences
cellular processes and biochemical pathways, potentially revealing novel therapeutic targets for other
muscle disorders associated with aberrant purine metabolism.

Public health relevance
Project Narrative Inborn Errors of Purine Metabolism are associated with an array of devastating neuromuscular, developmental and behavioral phenotypes. There are no effective therapies for these disorders because of a lack of understanding of the mechanisms driving pathology in the neuromuscular system. The aim of the proposed studies is to elucidate the etiology of myopathy associated with adenylosuccinate synthase deficiency to generate novel ideas for therapeutic intervention.